Inhibitory Learning as a Novel Mechanism of Prolonged Exposure: An Investigation of Laboratory and Mobile Health Measures

Prolonged exposure (PE) is a gold standard treatment for posttraumatic stress disorder (PTSD), but it
fails to fully resolve PTSD in approximately half of Veterans who initiate it. Better understanding the
mechanisms underlying PE could increase Veteran response rates by informing new therapeutic strategies to
enhance PE and more accurate methods for identifying who will benefit from PE. The main interventions
components in PE are a) imaginal exposures, which involve repeatedly describing the memory of a previous
trauma, and b) in-vivo exposures, which involve confronting safe yet distressing situations that resemble the
trauma. The effectiveness of PE exposures at ameliorating PTSD appears to largely depend upon their ability to
facilitate fear extinction, as operationalized by reduced fear when the exposure is performed again. In PE,
clinicians attempt to facilitate fear extinction (i.e., lower fear in future exposures) by focusing on within-session
habituation (WSH) – an acute decline in fear during the current exposure. However, WSH tends to poorly
predict future fear levels in the laboratory and symptom reduction during PE, suggesting it is an insufficient
marker of exposure effectiveness. Instead, fear extinction appears to be driven by inhibitory learning (IL),
wherein the memory of a feared outcome not occurring during a feared situation inhibits fear when the same
situation is encountered again. Within exposures, IL can be measured by how much the patient's conscious
expectation of their feared outcome (i.e., threat expectancy) decreases after the outcome fails to occur. IL, as
indexed by reduced threat expectancy following each exposure, has shown promise as a mechanism of
exposure therapy for anxiety disorders. However, the role of IL in PE for Veterans has yet to be investigated.
To address this gap, the proposed study will use a multimodal collection of clinical, laboratory, and
mobile health measures to systematically evaluate whether IL is predictive of fear extinction and symptom
reduction during PE for Veterans. 80 Veterans with PTSD will complete a standard course of PE over
telehealth. Mobile health technologies will be used to assess IL (i.e., changes in threat expectancy ratings from
pre- to post-exposure) and fear-related responses (i.e., peak levels of subjective distress and physiological
arousal during each exposure). Participants will also complete a behavioral fear extinction task prior to PE that
will assess their capacity to experience IL, as measured by how much their expectancy for an aversive stimulus
decreases following instances where it does not occur. Our overarching hypothesis is that each measure of IL
will predict better fear extinction during exposures and more improvement in PTSD symptoms during PE. We
will specifically examine whether greater reductions in threat expectancy during each exposure type (imaginal
and in-vivo) predict lower peak levels of subjective fear and physiological fear during subsequent exposures
(aim 1) and whether these same IL measures also predict lower PTSD symptoms in subsequent PE sessions
(aim 2). These aims will allow us to determine whether threat expectancy offers a better marker of therapeutic
progress during PE exposures compared to the current method (i.e., WSH). In addition, we will examine
whether the capacity to experience IL, as measured within a behavioral fear extinction task at pretreatment,
predicts a steeper decline in PTSD symptoms during PE (aim 3). This aim will allow us to determine whether a
pretreatment measure of IL capacity can be used to accurately determine a Veteran's potential to benefit from
PE. Through this study, the applicant will merge his prior experience with laboratory threat learning research
with new mentorship in a) conducting clinical research studies of PTSD, b) evaluating treatment mechanisms
with intensive longitudinal data and mobile health technologies, and c) assessing fear extinction and
psychophysiology in Veterans with PTSD. This training will prepare the applicant to embark on a VA research
career that seeks to apply laboratory models of cognitive-emotional processes to improve our understanding
and delivery of exposure-based treatments for Veterans with PTSD and other related conditions.

Public health relevance
Posttraumatic stress disorder (PTSD) is one of the most common and debilitating health conditions among Veterans. Prolonged exposure (PE) is an effective treatment for PTSD that is commonly used in the VA, but it often fails to fully resolve PTSD in Veteran patients. Inhibitory learning is thought to be a driving force behind symptom reduction in exposure-based therapies like PE, but its role in PE has yet to be evaluated. By establishing inhibitory learning as a mechanism of PTSD improvement during PE, this study will validate a new therapeutic target that can be used to make PE a more effective and precise treatment. Additionally, by showing that inhibitory learning abilities at pretreatment predict PTSD improvement during PE, this study may produce a novel tool for determining which patients to enroll in PE. In this way, the proposed study has the potential to enhance the effectiveness of PE for all Veteran PTSD patients and yield an innovative method for identifying the specific Veterans who are most likely to benefit from this commonly used intervention.